Sequence determinants of membraneless organelle rheology

PROJECT ABSTRACT
An abstract is not applicable for this administrative supplement; a summary of the parent grant
can be found in the Research Strategy.

Public health relevance
PROJECT NARRATIVE This is an administrative supplement request for NOT-GM-22-009, under award 1R35GM142903-01 (PI: Schuster,Benjamin).